RML Core

RML Core Project Summary
Maximizing creative partnerships to deliver community-driven health outreach, the RML Team
contributes to the development of a robust healthcare workforce and reaches all populations by fostering outreach, engagement, and training.
These programs enable NNLM members to bring biomedical, health, public health and environmental health information resources and data within easy reach of researchers,
health professionals, the public health workforce, educators, and the public.
The RML Team:
• Activates large-scale outreach projects with proven partners to replicate programming
throughout Region 1 and nationally.
• Delivers a technology improvement program dedicated to health and digital access.
• Develops a data-ready workforce in collaboration with The Carpentries.
• Increases student engagement and contributes to the development of a robust
workforce by tailoring curriculums and outreach models for specific health careers.
• Launches an annual virtual symposium related to NNLM initiatives.
• Pilots a meaningful program on end-of-life care, partnering public libraries and
community-based organizations with hospitals for implementation.